Beta cell exhaustion and glucotoxicity in Diabetes

Project summary
Diabetes is characterized by progressive loss or dysfunction of pancreatic insulin-
producing β-cells. Previous efforts demonstrated loss of β-cell identity, rather than cell
death, as a primary contributor in loss of functional β-cell mass in diabetes progression.
Strikingly, this process is reversible, challenging the notion of permanent β-cell damage
in diabetes. However, underlying mechanisms remain elusive, and we have poor
understanding of the window for intervention to preserve or restore functional β-cell
mass. The long-term goals of this project are to understand temporal progression and
underlying mechanisms of loss of pancreatic β-cell identity in diabetes. In this proposal
we seek to understand β-cell adaptation to metabolic changes and conditions, determine
the temporal progression and underlying mechanisms of loss of β-cell mass and identity
in diabetes in vivo, and ways to prevent or restore functional β-cell mass. Proposed
studies will utilize novel inducible mouse models of monogenic neonatal diabetes and of
polygenic type 2 diabetes to understand β-cell adaptation to changes in metabolism,
determine the temporal progression and underlying mechanisms of loss of functional β-
cell mass and identity in different forms of diabetes, the role of autophagy in this
process, and mechanisms to mitigate glucotoxicity-induced β-cell failure. Successful
completion of the proposed aims will provide new molecular and mechanistic insights
into the adaptive potential of β-cells and will shed light on mechanisms to preserve β-cell
mass and identity.

Public health relevance
Narrative Diabetes is characterized by progressive loss or dysfunction of pancreatic insulin- producing β-cells. Unique animal models of different forms of diabetes reiterate the main features seen in the human disease. Proposed experiments will use these animals to determine temporal progression and underlying mechanism of loss insulin producing β- cells and identity ways to preserve or reverse these features. This work may lead to develop new approaches to restore or preserve β-cell function and therefore their response to antidiabetic drugs in individuals with diabetes.